CORE--CHEMISTRY/RADIOCHEMISTRY FACILITY

Specialized Resource 1-Chemistry/Radiochemistry Resource (Drs. Chen/Rao Co-Pi's): This resource is designed to help ICMIC at Stanford investigators with their needs for radiochemistry and synthetic organic chemistry. Since the design and utilization of chemistry probes is at the core of molecular imaging it is important that ICMIC at Stanford investigators have available routinely utilized PET tracers (e.g., FDG, FHBG, FIAU, FLT) as well as the ability to help investigators with custom synthesis. Support for lodinations for PET and SPECT tracers is also provided. Furthermore, because the evolving needs of investigators may require totally new chemistry; this resource will also help researchers with synthetic organic chemistry. This resource is utilized by all four Research Projects. As more investigators start to use microPET we expect this resource will be further utilized.